Peer-Based Approaches to Enhance Physical Activity in Dyads of Inactive Women

ABSTRACT
Most adults in the U.S. fail to meet national physical activity (PA) recommendations, and minorities are less
likely to meet these recommendations than non-Hispanic Whites. Physical inactivity and obesity are major risk
factors for cardiovascular disease, certain cancers, diabetes, and stroke and are important contributors to
preventable morbidity and mortality in the U.S. Social environments are widely recognized to have an
important impact on PA, yet social contexts remain understudied in intervention research. The goal of the
proposed research is to evaluate the effectiveness of a 6-month behavioral dyadic intervention to promote
positive and sustained change in PA among inactive predominantly Latina and African American women in
Houston, TX. Dyads will first be randomly assigned to the dyadic intervention or to an individual condition.
Within the individual condition, one woman from each dyad will subsequently be randomized to the individual
intervention and the other woman to a health education control. The dyadic and individual interventions will
consist of telephone-based health coaching, a Fitbit, and health education newsletters to enhance motivation
and behavioral skills for increasing PA. The health coaching for the dyadic intervention additionally focuses on
building participants' capacity to be a supportive partner by training dyads in positive communication strategies
and offering support in a non-judgmental and empathetic way. The health education control will consist of a
Fitbit and health education newsletters. Study participants will include 500 predominantly Latina and African
American inactive women recruited and enrolled as dyads (e.g., family or friends; n=250 dyads). The
intervention expands upon a pilot randomized trial conducted by the investigative team that showed preliminary
evidence of support and also identified areas for improvement. Participants will be assessed at baseline, 6
months, and 12 months after baseline to evaluate both intermediate and long-term effects. The primary
outcome is change in minutes per week of moderate-intensity PA. Lower body strength, anthropometric
measures (i.e., BMI, waist circumference), sedentary behavior, mean daily steps, and blood pressure are
secondary outcomes. Autonomous motivation, social support, autonomy support, self-efficacy, and outcome
expectancies will be examined as potential mediators of changes in PA. The proposed research is innovative
in its comparison of a dyadic intervention against an individual intervention and in its emphasis on dyadic social
processes in addition to standard behavior change strategies. The intervention explicitly targets existing social
networks to foster social environments supportive of healthy behavior change that will persist beyond the
intervention period. This research is expected to yield critical insight regarding whether and how features of
social contexts can be modified to support healthy lifestyle change as a means of addressing disparities in
cancer and chronic disease risk among predominantly Latina and African American women.

Public health relevance
NARRATIVE The proposed research seeks to address racial/ethnic disparities in chronic disease risk by evaluating a novel dyadic behavioral intervention focused on motivation, behavior skills, and building women's capacity to be a supportive partner to increase physical activity in dyads of inactive predominantly Latina and African American women. Research will yield critical insight regarding the effectiveness of dyadic approaches and how best to facilitate greater collaboration and support for increased physical activity among inactive women.